Biostatistics & Data Science Core

Core G: Biostatistics and Data Science
ABSTRACT
The Biostatistics and Data Science Core (Core G) plays a critical role within the Penn CFAR by ensuring
that studies carried out by CFAR investigators employ optimal statistical approaches that result in
scientifically rigorous, high quality, reproducible, impactful discoveries. To do this, Core G provides (a)
high quality expertise in statistical design and analysis of research studies; (b) support for database development
and management critical for CFAR investigations; (c) leadership in evaluating, developing and disseminating
optimal statistical methods for HIV-related research; (d) education, training, mentorship in statistical methodology
in order to ensure the highest level of methodological standards; (e) capacity building with the CFAR's
international partners in Botswana; and (f) a central nexus for engagement of the broad epidemiology, statistics
and informatics faculty in high priority HIV/AIDS research.
Core G is led by Drs. Susan Ellenberg (Director) and Pamela Shaw (Co-Director), along with Dr. Alisa Stephens-
Shields (Core Investigator); and Mr. Chris Helker, who oversees data management activities. Core G provides
statistical and data management input into studies being developed for funding applications by CFAR
investigators, postdoctoral researchers and students working in the labs of CFAR investigators, and frequently
assumes important leadership roles in funded projects. The Core supports both project-specific databases and
the CFAR Clinical Core Adult/Adolescent Database of >3000 subjects and the linked specimen repository.
Mentoring, over and above advice on specific projects, is a major focus, and Core G presents seminars on
statistical methods in clinical and laboratory research, and provide design and analysis in support of
Developmental Core Pilot Grants. International capacity-building activities of Core G include leading an initiative
to develop a biostatistics curriculum at the University of Botswana (UB) together with UB colleagues, and
extensive involvement in several additional Botswana-based training programs.
Looking ahead, Core G will continue its highly successful current activities, and in addition will lead the
development of expanded CFAR collaborations with the Philadelphia Department of Public Health in
collaboration with the Administrative and Clinical Cores, increase outreach to engage non-AIDS investigators in
the Statistics and Epidemiology communities, and leverage and engage the expertise of the newly-established
and rapidly-growing Penn Institute for Biomedical Informatics to expand use of natural language processing and
other emerging informatics technologies by CFAR investigators.